Methods and tools to integrate multi-omics datasets to understand preclinical autoimmune and immune-mediated diseases

ABSTRACT
Autoimmune or immune-mediated diseases affect 10% of the world population, and most conditions have no
cure. Existing treatment options are often broadly acting and have numerous side effects. Autoimmune diseases
often have a preclinical phase where a subset of symptoms occur, but they usually do not yet meet the diagnostic
criteria for the disease stage. Many conditions may also have an early stage where the symptoms are milder.
Early diagnosis at the preclinical phase or early disease stage is challenging as the symptoms are usually non-
speciﬁc. Moreover, only a fraction of individuals will progress to disease stages, which poses challenges for
clinical interventions. Understanding the genetic basis for preclinical immune-mediated diseases and dissecting
risk factors that underlie the progression from preclinical to disease stage is critical. In this application, we
propose to develop a series of methods and software tools to better detect genetic associations with preclinical
to disease stage progressions, perform integrative genomic analysis to identify genetic signatures underlie the
progression, and dissect genetic contribution to sex differences in autoimmune diseases. The methods and tools
will be broadly applicable to a myriad of diseases. The proposed development received enthusiastic support
from researchers studying psoriasis, Sjogren's disease, lupus, vitiligo, etc. The proposed new tools can
profoundly impact the understanding the genetic basis for preclinical diseases.

Public health relevance
NARRATIVE Autoimmune and immune-mediated diseases affect ~10% of the total population and are strongly inﬂuenced by genetic risk factors. These diseases severely affect the quality of life and can lead to fatality in their advanced stages. Early diagnosis and intervention in the preclinical phase before the diseases fully develop are critical for slowing down the progression, mitigating symptoms, and improving the quality of life. Developing software tools to understand the genetic risk factors that affect the progression from preclinical phase to disease states is of great public health relevance.